AFRPS Maintenance

The Michigan Department of Agriculture and Rural Development (MDARD) Animal Feed
Program (AFP) will enhance animal feed safety through the Animal Feed Regulatory Program
Standards (AFRPS) Maintenance Track. The AFRPS cooperative agreement will maintain best
practices, enhance animal feed safety and better direct regulatory activities aimed at reducing
foodborne illness attributed to animal feed safety hazards. Additionally, maintaining and
improving the eleven standards will provide greater efficiency, acceptance by FDA of MDARD
AFP field inspections and laboratory data, improve data quality and response time.
In this cooperative agreement proposal, MDARD AFP outlines goals and objectives on how it
will maintain a comprehensive strategic plan to continue significant conformance to the AFRPS.
In this proposal, MDARD AFP also establishes its ability to continue working with the state
laboratory in order to guarantee valid and defensible laboratory testing data to protect human
and animal health.
The continuous improvement of MDARD’s AFP through the AFRPS will assist both Michigan
and the FDA to better direct regulatory activities toward increasing food safety in the United
States and move closer to the goal of creating a national, fully integrated food safety system.

Public health relevance
If chosen to participate in the AFRPS Maintenance Track Cooperative Agreement the Michigan Department of Agriculture and Rural Development (MDARD) Animal Feed Program (AFP) will continue to build, improve, and maintain the eleven standards. This will include: • Reviewing the Regulatory Foundation Worksheet, Standard 1 • Revising the Field Competencies Recordkeeping Form, continue training two new field inspectors, and maintain CE training records for staff, Standard 2 • Continue to improve inventory data to focus resources on high risk firms and products, Standard 3 • Maintain auditing as required by Standard 4 • Continue to refine and enhance our investigation, recall, and consumer complaint procedures, Standard 5 • Review and evaluate our enforcement strategy, Standard 6 • Develop new and innovative ways to provide information to our stakeholders, Standard 7 • Review and improve the AFP Workplan by utilizing historical numbers to better calculate the number of FTE’s required in the program. Reevaluate the Implementation of AFRPS, Standard 8 • Maintain the AFP Improvement Plan, Standard 9 • Continue to plan and evaluate the AFP Sampling Plan, this includes reviewing how the AFP interprets the results and how the program handles enforcement, Standard 10 and 11